Integrative analysis of tissue-specific alternative splicing regulation under adaptive selection

Integrative analysis of tissue-specific alternative splicing regulation under adaptive selection
PROJECT SUMMARY
Tissue-specific alternative splicing (AS) generates multiple transcripts from single genes and contributes critically
to the cellular and phenotypic complexity of mammals. This process is tightly regulated by RNA-binding proteins
(RBPs) which recognize specific regulatory elements in their target transcripts. A long-standing hypothesis from
the evolutionary perspective is that changes of AS regulation due to mutations in cis-regulatory sequences
provide a major driving force of speciation in mammals, including closely related species such as human and
Chimpanzee. While recent studies convincingly demonstrated the pervasive species difference of AS in multiple
tissues, two fundamental questions remain: 1) which evolutionary splicing changes are under adaptive selection
in specific lineages because of acquired fitness advantages? 2) what are the underlying mutations that led to the
shifted selective regimes? These challenges are associated with the intrinsic degeneracy of the splicing code
and lack of effective computational and experimental approaches for direct comparative analysis. The primary
goal of this project is to overcome these limitations, so that we can identify divergent AS events under adaptive
selection and the causal mutations affecting important cis-regulatory elements. To achieve this overarching
goal, we formulated three specific aims. In Aim 1, we will use phylogenetic genetic methods to detect lineage-
specific changes in selection intensity and adaptive evolution of AS and map AS regulatory regions experiencing
lineage-specific adaptive evolution. In Aim 2, to elucidate the underlying regulatory mechanisms that led to
splicing divergence, we will systematically map divergent protein-RNA interactions and reconstruct the
evolutionary history in the phylogeny through a combination of CLIP footprints, perturbation of RBPs and
comparative genomic analysis. In Aim 3, we will focus on MAPT alternative exon 10, which is implicated in
frontotemporal dementia (FTD), and perform detailed analysis to reveal the mechanism of its divergent splicing
in primates and the associated functions at the cellular level. If successful, this study will advance our
understanding of the contribution of AS evolution to potential phenotypic differences among different mammalian
species and the underlying mechanisms. The strategy established in this study will also provide a new and
generalizable paradigm to better understand the splicing code.

Public health relevance
PROJECT NARRATIVE Alternative splicing (AS) is critical for expanding the complexity of genetic information encoded in the mammalian genome. Mutations affecting AS regulation provide an important source of genetic innovations during evolution, but are also implicated in an expanding list of genetic diseases ranging from neurological disorders to cancer. The proposed studies aim to investigate the divergence of tissue-specific AS regulation with acquired fitness advantages in specific lineages such as humans or primates, and explore the underlying mechanisms, which is highly relevant to understand human traits and susceptibility to genetic diseases.